Kaiser Washington Vaccine and Treatment Evaluation Unit – DMID 21-0004

The 21-0004 protocol will evaluate the safety and immunogenicity of SARS-CoV-2 administered during
pregnancy or postpartum. The Seattle Children’s Research Institute, a subcontractor to the Kaiser Washington
VTEU, has been selected to perform SARS-CoV-2 pseudovirus neutralization assays for the 21-0004 trial. The
NIH will provide funds for the assay work to the Kaiser Washington VTEU, which will then provide funds to the
Seattle Children’s Research Institute via the existing subcontract. Kaiser Washington is not a clinical site for
the 21-0004 trial and the work of the subcontractor is the only involvement of Kaiser Washington in that trial.

Public health relevance
The 21-0004 protocol will evaluate the safety and immunogenicity of SARS-CoV-2 vaccines administered during pregnancy or postpartum. The Seattle Children’s Research Institute, a subcontractor to the Kaiser Washington VTEU, has been selected to perform SARS-CoV-2 pseudovirus neutralization assays for the 21- 0004 trial. The NIH will provide funds for the assay work to the Kaiser Washington VTEU, which will then provide funds to the Seattle Children’s Research Institute via the existing subcontract.